Novel, automated mobile heart rhythm analysis technology to start antiarrhythmic medications safely at home

PROJECT ABSTRACT
This proposal provides additional objectives to advance the research and entrepreneurial skills of the
postdoctoral candidate and the parent award, which aims to improve cardiovascular outcomes and quality of life
for atrial fibrillation (AF) patients by allowing them to safely start proven antiarrhythmic drugs (AADs). AF is the
most common heart rhythm disorder (>38M cases worldwide) and causes significant morbidity and mortality.
AADs reduce mortality unlike other AF drugs, but access is restricted by a three-day hospitalization required to
start these oral drugs. This is due to a rare (<0.6%) heart rhythm side effect that may require defibrillation and
can be avoided by heart rhythm analysis. During a “drug load” hospitalization, corrected QT (QTc) intervals from
patient electrocardiograms (ECGs) are manually measured and tracked, as QTc changes predict adverse
responses to AADs. For AF patients at low risk of proarrhythmia, the cost and risks of hospitalization may
outweigh the benefits. SafeBeat developed the first machine learning algorithm to produce visually verifiable
QTc measurements for any ECG format, enabling easy review or modification from a mobile phone. The high
QTc accuracy (5±7 ms) enabled the algorithm to recommend AAD dosing with 95% accuracy compared to
physicians. This proposal is supported by cardiac monitoring device manufacturers, hospital systems, and key
opinion leaders in cardiology due to significant cost savings, improved long-term AF monitoring, and expanded
AAD access. The goals of this proposal are facilitated by 1) assessment of patient and provider interaction for
refinement of the SafeBeat platform, 2) evaluate patient and ECG characteristics as predictors of
pharmacological cardioversion using AAD therapy to determine the best candidates for use of the platform, and
3) perform longitudinal follow up of study participants for usability and efficacy data.

Public health relevance
PROJECT NARRATIVE Over 38 million people worldwide suffer from atrial fibrillation, but access to heart rhythm drugs is restricted by the required three-day hospitalization to start these oral medications due to rare but dangerous side effects. The objective of this Supplemental Diversity in SBIR proposal is to support the parent award through appropriate sub-activities that bolster the research and entrepreneurial skills of the postdoctoral candidate.